Targeted disruption of the YAP/TAZ/TEAD axis in pancreatic cancer

Project Summary
(as stated in parent grant)
Pancreatic ductal adenocarcinoma (PDAC) is a devastating form of pancreatic cancer with
dismal patient outcome. KRAS, which is commonly mutated in PDAC, is a driving oncogene in
this disease. However, development of approaches to target KRAS has proven challenging and
inhibitors targeting signaling networks downstream of KRAS such as the MAPK pathway have
largely failed as single agents. The overall goal of this proposal is to use innovative chemical
strategies to identify combination regimens in PDAC, which are urgently needed to improve
patient survival. Combining CRISPR screens and epigenomic profiling, I identified that the
YAP/TAZ/TEAD axis is a critical transcriptional node required for the bypass survival program
upon KRAS loss or MEK inhibition. This data and published literature support the importance of
directly targeting the YAP/TAZ/TEAD axis in PDAC. However, current YAP/TAZ/TEAD
inhibitors have poor potency and off-target effects and genetic strategies to study critical
transcription regulators have limited utility due to delays between protein loss and experimental
measurement. To overcome these limitations, I developed a versatile tag-based technology
platform known as the degradation tag (dTAG) system to induce rapid degradation of any target
protein in cell lines and mouse models. The dTAG system enables evaluation of target protein
loss with a small molecule degrader in a time-scale that is not possible with genetic
approaches, facilitating evaluations of mutant KRAS, YAP and TAZ. In addition, the Gray
laboratory developed a selective small molecule covalent TEAD inhibitor to irreversibly
inactivate aberrant YAP/TAZ/TEAD signaling. The work proposed in this application will
leverage the dTAG technology platform and a covalent TEAD inhibitor to establish the role of
YAP/TAZ/TEAD in coordinating bypass survival in PDAC. In Aim 1, in the absence of direct
YAP or TAZ inhibitors, I will use the dTAG system to define the direct YAP and TAZ
transcriptional signaling program that promotes survival upon modulation of KRAS signaling.
These experiments will demonstrate the potential of chemical degradation of YAP and TAZ and
identify novel targetable vulnerabilities. In Aim 2, I will use PDAC cell lines and patient-derived
organoid models to evaluate the translational potential of covalent TEAD inhibition as a
combination regimen with KRAS signaling disruption. Integrating chemical biology, genome-
scale analyses, and translational models of PDAC, I expect that PDAC-specific therapeutic
insights will emanate from this work. To achieve these aims, I designed a 3-year plan that
includes participation in scientific and career development meetings, workshops and coursework
to further develop my cancer chemical biology and computational biology expertise. This career
transition award will greatly facilitate my goal of leading a multidisciplinary research laboratory
focused on addressing challenges in the treatment of pancreatic cancer.

Public health relevance
Project Narrative Pancreatic ductal adenocarcinoma (PDAC) is an aggressive form of pancreatic cancer with limited therapeutic options. The goal of this proposal is to identify combination treatment strategies that enhance existing PDAC therapies by chemically degrading or inhibiting key gene- regulatory proteins. This work will guide the deployment and development of targeted therapeutics aimed at proteins responsible for drug resistance mechanisms in PDAC.